Optimal physical activity timing and 24-hour activity composition for prevention of hypertensive disorders of pregnancy

PROJECT SUMMARY/ABSTRACT
De novo hypertensive disorders of pregnancy (HDP), including gestational hypertension and
preeclampsia/eclampsia, impact 10-15% of pregnancies and are considered salient risk factors for future
cardiovascular disease (CVD) in women. Moderate-to-vigorous physical activity (PA) is strongly recommended
for CVD prevention; however, there is currently limited evidence on the importance of PA timing (early vs. mid-
pregnancy and change across pregnancy) for HDP prevention. In addition, light-intensity PA has been linked to
better cardiovascular risk profiles in the general adult population, but few studies have investigated
associations of light-intensity PA during pregnancy with HDP, when light-intensity PA may be a more
achievable behavior and associations may differ due to pregnancy-associated cardiovascular changes. Finally,
previous research in the general adult population suggests the composition of the entire 24-hour day—which
includes sleep and sedentary behavior in addition to PA—impacts CVD risk and mortality; however, the optimal
24-hour activity composition for reducing risk of HDP remains unclear as few studies have considered more
than one behavior simultaneously. As behaviors are not independent within the context of the 24-hour day,
applying a 24-hour activity paradigm, including sleep, sedentary behavior, light-intensity PA, and moderate-to-
vigorous-intensity PA, is important for understanding these relationships. Identifying beneficial lifestyle-related
behaviors and combinations of these behaviors to reduce risk of HDP is of critical importance to inform the
development of clinical and public health guidelines and to promote lifestyle strategies to reduce CVD risk in
women. To address this critical gap, the proposed study will explore PA timing and intensity and optimal 24-
hour activity compositions at multiple pregnancy timepoints for reducing HDP risk. We will leverage Kaiser
Permanente Northern California’s diverse population of pregnant persons and extensive electronic health
record database, along with innovative 24-hour accelerometry, to conduct a longitudinal cohort study of 1,050
pregnant individuals with follow-up from early pregnancy through delivery. In early and mid-pregnancy, we will
collect device-measured 24-hour activity creating a large cohort with measurement of multiple aspects of PA
and sleep across pregnancy linked to de novo HDP identified by validated algorithms in the electronic health
record to determine prospective associations of PA in pregnancy by timing and intensity (Aim 1) and identify
optimal 24-hour activity compositions (Aim 2) with risk of HDP, and explore mediators and moderators of these
associations (Exploratory Aim). Results will elucidate the relationships between PA timing and intensities, and
optimal 24-hour activity paradigm, and risk of HDP. These findings will be paramount for guiding future PA and
24-hour activity guidelines for pregnancy and clinical trials of lifestyle interventions promoting healthy PA and
24-hour activity in pregnancy, which have the potential to improve long-term maternal cardiovascular health
and reduce the high morbidity and mortality from CVD in women.

Public health relevance
NARRATIVE This project is relevant to public health because results will elucidate the relationships between physical activity timing and intensity, broader 24-hour activity compositions, and risk of hypertensive disorders of pregnancy. Findings will be paramount for guiding future physical activity and 24-hour activity guidelines for pregnant individuals and clinical trials of lifestyle interventions promoting physical activity and 24-hour activity in pregnancy, which have the potential to improve long-term maternal cardiovascular health and reduce the high morbidity and mortality from cardiovascular disease in women. The proposed research is relevant to the mission and strategic plan of NHLBI calling for research on prevention of women’s heart, lung, blood, and sleep disorders related to physical activity during the reproductive years.